I: Penn State Institutional Career Development Core

Contact PD/PI: Sinoway, Lawrence Isaac Inst-Career-Dev-001 (002) 5 . & + & ,! & 1 )- $,1 & %( , ' $& $ & ,* &+$ ,'& $ + & * + * ! /$$ ! . 1 * + * ! *+ /!' * ,* & & * '*'-+ * + * ! % ,!' '$' + & )-(( ,' & . , ( ,!/ 1 *'% + + '. *1 ,' %(*'. ! $,! ! '. * $$ ' $ ' ,! && , , $& $ & * &+$ ,'& $ & &+,,-, 3+ &+,,-,'& $ * * . $'(% &, *' * % + ,' $ * , + !'$ * ,* &+,'& ,' * + * ! & ( & & -* (*'*, + & $- & * +& ,! * $ ,!& & + &, . *+,1 ' '-* + !'$ *+ -,$2& &&'. ,. +,* , + ,' & & - + !'$ *+ ,' &! & * + * ! (*' - ,.,1 0, & & & % &, & *-* $ ! $,! * + * ! & * && '-* , *. & '&,&-'-+ (*' * %% , %(*'. % &, /$$ * *-, + !'$ *+ /,! '-,+, & & (', &, $ ,' '% , $1+,+ '* &&'. ,'& & '% $ * + * ! ,* &+$ ,'& & ,!+ (($ ,'& / .-1/0 /1,,+.0 #+. / %+( ./ *! % 2 * &*/0&010&+* ( +))&0)*0 #+. * !!&0&+* ( / %+( ./ $$ * &, -& & &+,,-,'& $$1 -& + !'$ *+ /$$ + $ , ,!*'- ! &. *+,1 / ! . ++ ,' ,! + % * * . $'(% &, '(('*,-&, + & + % 0( , ,'&+ '* (*' * ++ ,'/ * . $'(% &, ' + &, & ( & & ! + $ , + !'$ *+ /$$ &*'$$ & & &, &+. 1 * (*' * % + & ,' (* ( * ,! & 0, & * ,'& ' $ *+ & -* %+ * ,' .1&0 *! *$ $ 0 (*0! / %+( ./ #.+) !&2./ '$.+1*!/ &* +(( +. 0&2 (&*& ( *! 0. */( 0&+* ( / &* / .. !2(+,)*0 ),()*0 * &*0*/&2 )*0+.&*$ + %&*$ /0. 0$3 #+. 1..*0 *! . *0 / %+( ./ 0+ 601.* 0% 1.27 +* / %+( . 0. */&0&+* 0+ &*!,*!* 2. $ 0% /0.*$0%/ +# +1. 8/ .1. ( *2&.+*)*0 , .0*./%&,/ *! 0 %*+(+$&/ 0+ !2(+, ./ . % ,. 0& 1) &* .1. ( % (0% #&* ,.+ /// #+. +(( 0&+* * (3/&/ *! 10&(&4 0&+* +# 2 (1 0&2 ! 0 $1&!! 3 0% (+$& )+!( 0+ #+/0. +*0&*1+1/ -1 (&03 &),.+2)*0 +# 0% .. !2(+,)*0 ,.+$. ) * ' &2 %-$,($ ,'*+ '&,* -, ,' ,! + !'$ *+3 ,* &+,'& ,' & ( & & & $- & ,! * &, ,. ( *++, & * +$ & +-(('*,. % &,'*+!( &, * ,'&+ /,! '$$ '* ,'*+ (*', , * + * ! ,% & ,! &+,,-,'& $ * + * ! & * +,*- ,-* & -$,-* %& '* %$ +,'& + '& ,! ( ,! ,'/ * & ( & & $+' . * + ( & & '& ! & . - $3+ (*'* ,* && -* (*' * %% , ' *& + * ''* & , /,! ,! * &+$ ,'& $ & .'*+ '* ,! '%%-&,1 & + * ! '* & ,! (*' * % & & $- . & * + '* + %& *+ 0( * &, $ '(('*,-&, + & . - $ '-*+ + $ *&& %' -$ + & $ 0 $,1 '* & . - $2 $ *&& &, & '-, '% + * '%( , &, ,* &+$ ,'& $ * + * ! *+ /,! +#$$+ ,' $ * , + '. *1 1 * & (+ & &&'. ,'& $'& ,! ,* &+$ ,'& $ * + * ! '&,&--% Project Summary/Abstract Page 873 Contact PD/PI: Sinoway, Lawrence Isaac Inst-Career-Dev-001 (002) 5 2*3 $2 -/4 +/+ - $ */ %- -%(+1 -+0, / $6'37/8/43 84 3*+5+3*+3)+ .'6')8+6/78/)7 '3* 98)42+7 4, +3846+* '6++6 +:+1452+38 #).41'67 '8 1/3/)'1 '3* $6'371'8/43'1 #)/+3)+ ;'6* 378/898/437 2*3 -0) ( * + % $+(. +2-3( ' $+% -)&+ -/%* () *. ) 3+ 1*,+-/ 0-*$ ) %*!. *%#$/ ++!. %*#.)+- %*. 0-# +*# -*(( *# +(! 2- ++- ) -# $ /-% . (%' *#- 1%/ *#(3 )42293/8= '5564'). 84 2468'1/8= 56+*/)8/43 /3 7+57/7 :/' -+3+ +<56+77/43 '3'1=7/7 # ( *2 ( % 4 - * !+. #.$ 2 $%*' ( *' !64248/43 '3* 8+396+ 541/)/+7 ,46 8+'2 7)/+3)+ '8 )411+-+7 7).4417 4, 2+*/)/3+ ! -/%* 0/-% -! 2%. 7978'/3'(1+ )4967+ /3 6+7+'6). 2+3846/3- ! -.!* ).+* ,/+* *:4)')= 6/:+7 64;8. 97842+6 *:4)')= 6/:+7 % 97/3+77 64;8. # ! & ! 0*./%* +,'918 91+7 6+ +88+6 $.'3 )8/:+ .447/3- ,8+3 ! 0*#$ *. !- )%*#2 3 %))%. +*. +)69/8/3- 5'8/+387 84 2+*/)'1 6+7+'6). *49(1+ (1/3* 6'3*42/7+* 86/'1 4, 458 /3 :+6797 458 498 786'8+-/+7 %(1% % # # $ &'7./3-843 2+6/)'3 !7=).414-/)'1 774)/'8/43 +--./ $.(3 - -# - %./-3 +:+1452+38 4, 8.+ +'63/3- +'18. #=78+2 +7+'6).+6 46+ 425+8+3)/+7 $ ! +*4 (+ '$/3 - / -- +-' * -0*// * $- -* -/$(%* % 2.+* +*- ! 0((%1 * $2 -/4 '+ $( ' +'18. #=78+27 #)/+3)+ 966/)91' /3 %3*+6-6'*9'8+ +*/)'1 *9)'8/43 *+38/,=/3- '3* +,/3/3- ' !48+38/'1 966/)91'6 6'2+;460 + %*.+* $2 -/4 % #(%+ $(02 (% -%(+1 %3*+678'3*/3- '6++6 #9))+77 '3* 87 4386/(98/3- ')8467 ,46 1/3/)'1 '3* $6'371'8/43'1 3:+78/-'8467 #+1 !4591'8/437 %3*+66+56+7+38+* /3 8.+ <86'296'1 #)/+38/,/) &460,46)+ .8857 */:+67/8= 3/. -4: '(498 97 54591'8/43 93*+66+56+7+38+* References Cited Page 874